Nanoscale structure and function of desmosomes

Project Summary
Desmosomes are macromolecular cell-cell adhesive junctions that provide robust mechanical integrity to the
epidermis. They are composed of transmembrane desmosomal cadherins, which mediate cell-cell adhesion,
and intracellular plaque proteins including desmoplakin, which couple the complex to the intermediate filament
cytoskeleton. The functional importance of desmosomes in the skin is highlighted by a variety of inherited human
disorders with erosive skin and mucosal phenotypes, that also may affect hair or heart, for which there are limited
treatment options. To understand the interplay between desmosome structure and function, it is crucial to
appreciate how individual proteins contribute to the overall organization of the desmosome. Yet, due to the size
and molecular complexity of desmosomes, there is a lack of tools to study this structure-function relationship,
creating a critical barrier in this field. To address this challenge, we will use a multi-disciplinary approach to test
the hypothesis that the biophysical organization of proteins in the desmosome provides a mechanism to regulate
adhesion. We developed two highly innovative and complementary super-resolution fluorescence microscopy
approaches to study protein architecture in desmosomes. Our goal is to elucidate how the order and organization
of proteins impact the adhesive function of desmosomes in healthy and disease states. In Aim 1 we will define
the mechanism and driving desmoplakin architectural changes and the role of desmoplakin architecture in
providing mechanical integrity. In Aim 2 we will define the mechanism that confers order to desmosomal
cadherins. In both aims genetic disease associated variants will be introduced to identify architectural
contributions to disease mechanism. We will combine innovative fluorescence microscopy with primary human
keratinocytes, mechanical stimuli, protein chimeras, and disease associated variants to test the hypothesis that
desmosome architecture is inseparably linked to adhesive function. Completion of these goals will provide insight
into the fundamental mechanisms of protein architecture that driving desmosome function in healthy and disease
states.

Public health relevance
Project Narrative Aberrant desmosome function is linked to numerous human diseases impacting the skin. The goal of this proposal is to provide novel insight into how desmosome structure and architecture are mechanistically linked to function through super-resolution imaging. These studies have important implications for development of targeted therapeutic strategies to modulate the structure of desmosomes in epithelial disorders.